Administration and Biostatistics Core

The purpose of the Administrative and Biostatistics Core (Core A) is to coordinate the administrative and fiscal
activities of the PPG, to provide biostatistics support for all of the Projects, and to ensure rigorous experimental
design and data analysis for all the Projects. Dr. Linton will provide oversight for all functions of Core A. Mr.
Nicholas Jenkins, Grants Manager, will work closely with Dr. Linton to provide fiscal oversight and management
of the budgetary aspects of the PPG’s Projects and Cores, including compliance with institutional policy and
implementation of grant policy for post award management. Mr. Jenkins will assist with budgets related to grant
submissions, including competing and noncompeting renewals. Ms. Lawrence will oversee the financial aspects
of the administration of the budget. She will supervise and coordinate communication with the Grants Manager
and the Administrative Officer. Maria Peng, Administrative Officer, will prepare monthly budget statements for
the Projects and Cores for the Investigators. She will be responsible for PPG reports and administration of
finances for the service Cores and the Projects. Ms. Lawrence and Ms. Bartkus, the administrative assistant, will
be jointly responsible for generating purchase orders for equipment and reagents for all of the PPG Projects and
Cores, and for expenditure reconciliation. Ms. Bartkus will also help with arranging the monthly meetings of PPG
Project Leaders, investigators and Core Leaders, organize seminars, meetings with advisors and handle PPG
related travel. She will ensure that all human subject and animal use documentation is current. The Biostatistics
portion of Core A will provide statistical expertise for all projects and investigators to ensure rigor and
reproducibility for all PPG projects. Drs. Ye and Du will continue to work closely with project leaders and will
be available to all PPG investigators to provide state-of-the-art statistical support. To ensure statistical
reproducibility, for each PPG-associated analysis performed, a statistical report in HTML or PDF format will be
generated, which will document the R programming codes and any simulation seeds used in the analysis.
Additionally, all model development procedures will be internally validated using cross-validation or bootstrap
methods. The Biostatistics Core supports all 4 Projects. Bioinformatics support will be provided in Core D: The
Non-Coding RNA and Bioinformatics Core.